STRESS AND SUSCEPTIBILITY TO INFECTIOUS DISEASE

The objective of this study is to investigates the role that stressful life events and personality characteristics play in susceptibility to infectious agents. Following psychological and personality evaluation, a human respiratory disease model will be used to experimentally control exposure to a virus and to monitor the development of both infection and clinical illness in normal subjects.